Individualized Closed Loop TMS for Working Memory Enhancement

ABSTRACT
The proposed project is designed to increase precision and responsiveness in transcranial magnetic
stimulation therapies across the neuropsychiatric spectrum and specifically in working memory deficits which
are common across a variety of neuropsychiatric conditions. Cutting edge functional imaging studies suggest
that using multiple types of imaging datasets yield more reliable estimates of brain network communication.
Our methods yield a combined resting and task fMRI functional network mapping individualized for each
participant that will allow precise identification of brain stimulation targets associated with optimal working
memory performance (Aim 1). To close the loop in designing TMS protocols that respond to an individual
person's brain activation state, we will also develop and test a real-time brain decoder to determine when
optimal working memory states are online (Aim 2). By iteratively testing excitatory neuromodulation
frequencies at this stimulation site and capturing the relative movement of brain states towards or away from
optimal working memory states, we will settle on the optimal frequency for augmenting working memory
performance in each individual (Aim 3). We will validate this approach by administering either the `best' or
`worst' (random assignment to each participant) neuromodulation protocol across several days then testing
working memory performance and brain activation in a final MRI scan session. The multi-modal based TMS
targeting and individualized frequency optimization techniques will be based on our findings and packaged into
a combined software suite in Docker containers made available to the scientific and clinical community at the
conclusion of this project (Aim 4).

Public health relevance
NARRATIVE The next generation of brain stimulation therapies for mental health disorders will be more individualized and will use cutting edge neuroscience and brain imaging techniques to guide them. To propel this transition, we will develop a more spatiotemporally precise and reliable target for transcranial magnetic stimulation as well as a stimulation frequency chosen for each individual based on functional MRI and in-scanner TMS readouts that optimize working memory brain states for each participant. The integrated targeting and neuromodulation tailored to each person will be accomplished with a single software suite that will be the product of this investigation and will help scientists and clinicians to accomplish robust individualized targeting and effective brain responsive neuromodulation.